Lipid nanomedicine targeting multiple signaling pathways of medulloblastoma

PROJECT SUMMARY
Medulloblastoma (MB) is the most common childhood brain tumor arising from the cerebellum. Many factors
influence the proliferation, differentiation, and migration of cerebellar granular neuronal precursor (GNP). Among
them, MDM2 is a major nexus between tumor suppressor TP53 and hedgehog (Hh) signaling in GNPs and
promotes MB tumor growth and metastasis. In addition, PI3K and BRD4 signaling also play key roles in MB cell
growth, cancer stem cell (CSC) proliferation, and tumorigenesis. Further, MB treatment is challenging due to the
development of chemoresistance, inefficient drug transport across the blood brain barrier (BBB) and drug
induced neurotoxicity. Hh inhibitors are effective initially to treat SHH-MB, but their repeated use develops
chemoresistance due to mutations in smoothened (SMO) but can be overcome by modulating GLI, which is
downstream of SMO. In our preliminary studies, we synthesized a series of potent BRD4/PI3K dual inhibitors
by modifying structure of parent compound SF2523. One of the compounds 8-(2,3-dihydrobenzo[b][1,4]dioxin-
6-yl)-2-morpholino-4H-chromen-4one (abbreviated as MDP5) was found highly potent. We then determined X-
ray crystal structures of the recombinant BD1 and BD2 domains from BRD2 in complex with MDP5. While MDP5
showed higher potency in DOAY cells compared to SF2523 (12.6 µM), IC50 values for MDP5 and SF2523 were
similar potency on HD-MB03 MB (MYC amplified) cells. MDP5 decreased the target downstream proteins like
p-AKT, MYCN, Cyclin D1, and increased the degradation of MYCN protein indicated by p-MYCN (ser 54). We
also discovered a small molecule JW-475A which is a potent dual MDM2 and XIAP inhibitor. MDP5 and JW-
475A (a dual MDM2 and XIAP inhibitor) effectively inhibited the proliferation of MB cells in a dose dependent
manner, with significantly higher cell killing when these drugs were used in combination. Treatment of MB cells
with the combination of these two drugs significantly decreased the colony formation capacity compared to
individual drugs. We prepared PEG-DSPE based lipid nanoparticles (LNPs) with 4.9±0.1% and 4.8±0.1% loading
for MDP5 and JW-475A. BBB penetrating targeted LNPs were prepared by surface decorating with rabies virus
glycoprotein (RVG) peptide-peptide. Our hypothesis is that inhibition of BRD4/PI3K and MDM2/XIAP
simultaneously using MDP5 and JW-475A represents a promising strategy to inhibit MB tumor in vivo. Further,
we will use RVG-PEG-DSPE LNPs to encapsulate MDP5 and JW-475A, which have poor drug transport across
the BBB. Our specific aims are to i) Synthesize novel MDP5 derivatives as dual function BRD4/PI3K inhibitors
and characterize in vitro activity; ii) Evaluate anti-cancer efficacy of JW-475A in combination with MDP5 in vitro.;
iii) Formulate MDP5 and JW-475A into LNPs decorated with RVG peptide and determine their biodistribution,
therapeutic efficacy, and systemic/organ toxicity in in SHH and MYC driven cells and PDX-based orthotopic and
transgenic SmoA1 MB mouse models. Long-term significance. Successful completion of this project will
provide a platform technology for treating brain tumors using this innovative LNP-based combination therapy.

Public health relevance
PROJECT NARRATIVE Brain-targeted combination therapy has the potential to treat medulloblastoma (MB) efficiently. However, multiple drug use often produces toxicity and result in significant neurocognitive deficits. We propose RVG peptide decorated lipid nanoparticles for co-delivery of potent BRD4/PI3K and MDM2/XIAP dual inhibitors.